Summer Research Experience for Medical Students in Inflammation and Infectious Diseases

PROJECT SUMMARY
We propose to introduce early stage medical students to the challenges and excitement of research by
providing a mentored summer research experience with the ultimate goal of inspiring trainees toward academic
careers that incorporate basic biomedical and clinical research. The T35 Research Training in Immunology and
Infectious Diseases (REIID) program will exist as a dedicated, NIAID-focused research and career
development program that leverages the successful administrative framework of the Student Training In
Approaches to Research (STAR) Program at Loyola University Chicago Stritch School of Medicine. The T35-
REIID program will provide students between their first and second year of medical school with a focused
eight-week mentored training experience pursuing NIAID-related research resulting in completion of a research
project and formal presentation of their work. The Stritch School of Medicine is a rich academic environment
and a leading institution in immunology and infectious disease-related research and clinical care. We have
assembled a team of twenty-four experienced, extramurally funded mentors whose research covers
epidemiology; genetics; molecular, cellular and pathophysiological mechanisms of disease; translational
research; and patient-oriented clinical research. The student’s full-time research training will be supplemented
with didactic conferences on topics including experimental design, data management, responsible conduct of
research, professional development, and presentation skills. Trainees will be chosen through a competitive
process based on their proposed research plan and goals for the summer experience. The T35-REIID program
includes student and mentor assessments to evaluate the quality of the research experience and didactic
offerings as well as our success at encouraging students to pursue academic careers that include research.

Public health relevance
PROJECT NARRATIVE The proposed training program provides mentored summer research opportunities for early stage medical students with the goal of inspiring a passion for biomedical research. Through hands-on research training supplemented with didactic conferences on research and career development topics, we will introduce students to the excitement and challenges of research and encourage them to pursue careers that integrate research with clinical care.